In vivo inflammatory challenge to elucidate the role of the toll-like receptor 4 pathway in depression

Project Summary
Approximately 1/3 of individuals with major depressive disorder (MDD) display inflammation that is believed to
play a causal role in the disorder, but the precise mechanisms are not understood. Experimental endotoxemia
studies in healthy individuals have shown behavioral, immunological, and physiological changes leading to a
transient depressive-like state that resolves 4-5 hours after administration of lipopolysaccharide (LPS). While
informative, these studies cannot reveal putative, aberrant inflammatory and regulatory mechanisms in MDD.
Hence, a mechanistic approach is required to pinpoint which immunoregulatory mechanisms are defective in
MDD. This proposal will leverage an experimental medicine study involving acute administration of LPS or
saline to individuals with MDD and healthy controls (HC) to identify depression-relevant changes in the TLR4
pathway and its regulation by microribonucleic acids (miRNAs) in both the blood and the brain. The central
hypothesis is that TLR4 signaling is sensitized in MDD by a history of exposure to exogenous (e.g. pathogens,
LPS from leaky gut) and/or endogenous (e.g. chronic stress) ligands, and thus, TLR4-mediated inflammatory
and regulatory mechanisms are impaired in MDD subjects compared to HC. TLR4 detects pathogen- and
damage-associated molecular patterns (PAMPs and DAMPs) for production of inflammatory cytokines, such as
interleukin 6 (IL-6) and tumor necrosis factor (TNF), which are elevated in some individuals with MDD. Whilst
PAMPs, like LPS play a role in the pathogenesis of MDD, stress-associated production of DAMPs may also
activate TLR4. Despite the theoretical importance of the TLR4 pathway, the evidence base is currently small,
the extant clinical data are cross-sectionally derived, and TLR4 downstream signaling has not been assessed
despite aberrant expression of TLR4-responsive miRNAs in MDD. These miRNAs can be isolated from
extracellular vesicles (EVs) that cross the blood brain barrier, thus, isolating EVs of glial origin will provide a
readout of CNS-associated TLR4 regulation in MDD. Our preliminary data suggest that the inflammatory
cytokines, IL-6 and TNF, as well as TLR4 are increased in MDD compared to HC in response to LPS. The K99
phase will identify peripheral and central TLR4-mediated immune signaling mechanisms in MDD with the use
of high-sensitivity, immunoassay detection to identify changes in cytokine expression and TLR4 pathway
proteins and support the PI’s training in flow cytometry, miRNA extraction, astrocyte-enriched EV (AEEV)
isolation, and RNA-seq. The R00 phase will identify peripheral and central TLR4-mediated regulatory
mechanisms in MDD with the use of Next Generation Sequencing to identify miRNAs dysregulated in MDD
and will provide support for transition to an independent investigator specializing in CNS-dependent TLR4-
inflammatory mechanisms in depression. The ability to delineate TLR4-mediated peripheral and CNS
immunoregulatory responses with cutting edge techniques, still novel to the field of psychiatry, will move us
one step closer to understanding the mechanisms underlying inflammation-associated depression.

Public health relevance
Narrative Inflammation is thought to play a role in the pathogenesis of major depressive disorder (MDD), but the exact immunoregulatory mechanisms are not well understood. This proposal will leverage an ongoing experimental medicine study using lipopolysaccharide to compare immune mechanisms and regulation of the toll-like receptor 4 inflammatory pathway in MDD and healthy participants in both the blood and the brain. The results may provide a roadmap for understanding how the immune system is dysregulated in MDD and for the identification of novel therapeutic targets.